Translating post-infarct ventricular tachycardia mechanisms into a therapy

ABSTRACT
In the United States, several hundred thousand people experience cardiac arrest each year, with the vast
majority dying from this condition. Approximately two-thirds of cardiac arrest victims have previously suffered a
myocardial infarction (MI), and death results from maladaptive responses to infarct healing. The healed infarct
scar creates a substrate that supports malignant ventricular arrhythmias, and death results from ventricular
tachycardia (VT) originating in the border zone around the infarct scar. The prevailing paradigm focused on
the role of surviving ribbons of myocardial tissue traversing the borderzone region and impaired electrical
conduction as components of the arrhythmia mechanism. A problem with ascribing causation of VT entirely to
those electrical conduction factors is that they occur diffusely throughout the borderzone, but VT exists in
discrete circuits. We recently reported that the potassium channel beta subunits KCNE3 and KCNE4 are
upregulated only in VT circuits, and that these proteins cause a pattern of repolarization heterogeneity that
supports reentrant VT. We have also shown that gene transfer of either repolarization prolonging or conduction
enhancing transgenes reduces or eliminates VT inducibility. We previously developed an epicardial gene
painting method for transmural atrial gene transfer, and we have preliminary data showing that use of
epicardial gene painting with adeno-associated virus vectors allows complete transmural ventricular gene
transfer. In this proposal, we exploit these findings to develop a cure for post-infarct VT. We hypothesize that
the VT circuit-specific repolarization effects combine with the more broadly present alterations in conduction to
create an environment conducive for reentry VT, and that normalizing repolarization and/or conduction will
prevent VT. To test our hypothesis, we will focus on 3 aims: (1) to homogenize repolarization in healed MI
scar; (2) to normalize conduction velocity and cellular connectivity by increasing intercalated disk expression of
connexin43; (3) to evaluate safety and biodistribution of the proposed interventions. Successful completion of
these aims will create a preclinical data package required to support future clinical testing of VT gene therapy.

Public health relevance
Project Narrative Cardiac arrest is the leading cause of death in the United States and other developed countries. In public discussions, these deaths are often called “heart attacks,” but in reality, they most often occur as a result of lethal ventricular arrhythmias. We previously identified unique elements of the electrical circuits that cause these ventricular arrhythmias. This proposal focuses on developing gene therapies to prevent these unique elements from supporting ventricular tachycardia, thereby eliminating these arrhythmias.